LIQUID HELIUM FILLING OF THE NMRFAM SPECTROMETERS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This narrative covers the time necessary for the filling of NMRFAM spectrometers with liquid helium. This includes the period of time necessary at the end of the filling period for the instrument to regain stability.